Improving Access to Lung Transplant Through Broader Geographic Sharing

Project Summary/Abstract
The sickest patients should receive priority access for organ transplant to avoid dying on the waitlist.
However, while high acuity patients comprise 10% of the U.S. lung transplant waitlist, they account for 60% of
lung transplant waitlist deaths. There are 59 Donor Service Areas (DSAs) in the U.S. whose boundaries were
created in 1984 based on the preferences of the few early transplant centers. Over the years, these boundaries
have created a system where 81% of donor lungs allocated within a DSA are to low acuity patients even when
a matched higher acuity patient exists just outside the boundaries in a separate DSA, resulting in an avoidable
waitlist death. This grant is premised on the notion that these geographic boundaries are an artificial allocation
criterion limiting access of high priority patients to lung transplant. It further serves as a response to a U.S.
government mandate to identify solutions to minimize the role of geography in organ allocation. The long-term
goal is to systematically address disparities in organ allocation; an example of which is the geographic disparity
in access to lung transplant. Evidence suggests that broader geographic sharing of other solid organs can reduce
avoidable waitlist deaths, however the role of broader sharing in lung allocation remains to be elucidated. The
central hypothesis is that broader geographic sharing of donor lungs will reduce avoidable waitlist deaths. This
hypothesis will be tested through two independent specific aims: (1) Compare the effect of waitlisting patients
in multiple DSAs vs one DSA on avoidable waitlist deaths. (2) Compare the effect of sharing donor lungs
beyond current DSA boundaries on avoidable waitlist deaths. This grant will also assess the impact of travel
costs on patients and transplant centers which may be a barrier to policy implementation. The proposed research
is significant because it could reduce avoidable waitlist deaths and have applications to other solid organ
transplants. The proposal is innovative because it is the first to apply known methodologies in economic modeling
to organ allocation to better understand the impact of policy changes on patients and transplant centers. This
research will be performed under the mentorship of Dr. Raed Dweik, who has extensive experience mentoring
K awardees and serves as director of the city-wide, multidisciplinary KL2 Scholars Program. A mentoring
committee which combines transplant expertise and a track record of guiding scientists towards R01
independence (Drs. Blackstone, Erzurum, Palmer, and Valapour) has helped create a career development plan
that will build towards a successful PhD degree. The objective is to gain skills that will build on the well-
established skillset of the mentors and collaborators which can only be earned through further education during
this early career phase. This application emphasizes a commitment to patient-oriented research, strong
mentorship, and the dedication of the Cleveland Clinic to training the next generation of independent R01 funded
physician scientists.

Public health relevance
Project Narrative This research is relevant to public health because it proposes modifications to existing U.S. donor lung allocation policy to eliminate geographic disparities and potentially reduce avoidable waitlist deaths. This will allow the field of lung transplantation to answer the federal mandate of the Final Rule issued in 1998 which urges prioritization of a patient's need for organ transplant over proximity to the donor with a goal of de-emphasizing geography in organ allocation; a mandate which the field of lung transplantation has made few advances towards over the past two decades due, in part, to a gap in knowledge which this grant aims to fill.